UTX: A novel regulator of decidualization?

Project Summary
During pregnancy, endometrial stromal cells transdifferentiate into decidual cells, a process
known as decidualization, to support the implanting embryos. The development of decidua with
full functionality requires coordinated cell proliferation, differentiation, and apoptosis. Despite a
series of elegant studies that have made breakthroughs in progesterone receptor signaling,
transcription factors, and growth factor signaling in uterine decidualization, the role of epigenetic
regulators remains poorly defined. Defective decidualization leads to pregnancy complications
such as miscarriage, intrauterine growth restriction, and pregnancy loss. Therefore, identification
of molecular mechanisms underpinning decidualization is of fundamental importance. Built on
novel preliminary findings using conditional knockout mouse model of UTX in the uterus, this
proposal will identify the function of a lysine demethylase, UTX, in the development of an integral
decidua and decipher how UTX regulates endometrial stromal cell differentiation. A multipronged
approach incorporating genetic, cellular, and molecular tools has been proposed. The findings
are anticipated to establish a new paradigm in understanding the role of epigenetic regulators in
uterine biology. Thus, completion of the proposed studies will have a substantial impact, with
potential translational implications in the treatment of endometrial dysfunction and pregnancy loss
associated with decidualization defects.

Public health relevance
PROJECT NARRATIVE Abnormal differentiation of the endometrial stromal cells upon embryo implantation causes miscarriage, intrauterine growth restriction, and pregnancy loss. Our proposed studies to identify new mechanisms regulating decidualization are relevant to the mission of NICHD to better women’s reproductive health. This proposal is expected to gain new insights into maternal-fetal biology and have potential translational implications in the treatment of endometrial dysfunction and early pregnancy loss associated with decidualization defects.